ACTG 370--3TC VS DLV IN COMBO WITH IDV AND ZDV/D4T

Evaluate the virologic and immunologic activity of continued 3TC versus Delavirdine in combination with IDV, ZDV, or D4T in 3TC-experienced subjects.